The Impact of Alzheimer’s Disease and Related Dementias on Nursing Home Care and Quality for Persons with Serious Mental Illness

PROJECT ABSTRACT
In 2016, nearly 800,000 Americans were long-stay nursing home (NH) residents. While 45% have dementia,
over 30% have a psychiatric diagnosis. In fact, NHs are the most important institutional setting of care for
adults with bipolar disorder, schizophrenia, or other psychotic disorders (“serious mental illness” [SMI]
hereafter). Individuals with SMI are more likely to spend time in a NH than counterparts without SMI, and the
proportion of NH residents with SMI has nearly doubled over the past decade, growing to 18.6% by 2017.
However, understanding NH care for SMI requires also considering Alzheimer’s disease and related dementias
(ADRD) because the conditions are inextricably linked: Among 55–64-year-olds with schizophrenia admitted to
NHs, 12.2% have ADRD, which grows to 80.5% among 85-year-olds, far exceeding the prevalence of ADRD
among the general population. Item C-4 of the NIA’s Strategic Plan highlights the need for “improved and cost-
effective ways to . . . improve older adults’ ability to cope with chronic disease,” while Milestone 13.N of the
AD+ADRD Research Implementation Milestones is focused on understanding mechanisms and sources of
disparities among those living with ADRD. SMI is comprised of chronic conditions for which older adults may
need extensive supports and experience significant disparities. Despite the growing population of NH residents
with SMI and their significant burden of ADRD, there is an enormous information vacuum about the care they
receive. In this explanatory mixed methods analysis, we will use the Minimum Data Set (MDS) paired with
linked resident, facility, and community characteristics to identify individuals in the U.S. admitted to a NH
facility. We will examine the characteristics associated with likelihood of becoming a nursing home resident,
specifically examining the risk associated with ADRD superimposed on SMI. Next, among those who become
long-stay nursing home residents, we will examine potentially avoidable hospitalization—again, focusing on
risk associated with ADRD superimposed on SMI. Among those with SMI, we will consider the quality of
mental health care (e.g., psychiatric hospitalization, use of restraints, antipsychotic prescriptions), examining
differences for those with and without ADRD. We will use this information to select performance outlier facilities
where we will conduct interviews with medical directors, nursing directors, consultant psychiatrists, and direct
care staff to identify barriers and facilitators to providing high quality care to residents with SMI impacted by
ADRD. We will integrate our quantitative and qualitative findings to identify key challenges and potential
solutions to improve care delivery to individuals with SMI and ADRD in NH. This innovative proposal will
provide crucial information critical to the goals of both the NIA overall Strategic Plan as well as the AD+ADRD
Research Implementation Milestones.

Public health relevance
PROJECT NARRATIVE Nursing homes are the most important institutional setting of care in the U.S. for older adults with serious mental illness such as schizophrenia and bipolar disorder, who comprise a growing proportion of nursing home residents. At the same time, these older adults have far greater risk for Alzheimer’s disease and related dementias (ADRD) than the general population. Using national data including the Minimum Data Set and Medicare claims, we will examine the care that nursing home residents with serious mental illness receive and how the presence of ADRD further impacts care quality, followed by semi-structured interviews with nursing home leadership and clinicians to help interpret our quantitative findings and identify barriers and facilitators to providing high quality care to residents with SMI impacted by ADRD.